PRENATAL BEHAVIORAL HEALTH RISK ASSESSMENT AND INTERVENTION PROGRAM

This is a 30-minute, patient interactive, comprehensive computer interview which queries obstetrical patients' lifestyle habits, stressful life situations and nutritional intakes. Purpose is to assess patient acceptance of program; determine acceptability of computer interviews; to assess truthfulness of reports to the computer; evaluate the educational value of program. Accuracy of reported lifestyle behaviors will be validated by urine biochemical analyses.